A First-in-Class Therapeutic Antibody for Treatment of Acromegaly

Project Summary: Acromegaly is a chronic, rare endocrine disorder that affects approximately 21,000 adults in
the US that is most often caused by a non-cancerous pituitary tumor that secrets excess growth hormone. Left
untreated, chronic overproduction of growth hormone and subsequent stimulation of insulin-like growth factor-1
in other tissues shortens the the average life expectancy by 10 years from diagnosis. The disease is associated
with 2- to 3-fold increased mortality and serious health complications and comorbidities. These include
cardiovascular disease, respiratory disorders, and metabolic diseases such as type 2 diabetes and impaired lipid
metabolism. The broad consensus is that effective treatment is achieved by strict growth hormone control,
demonstrated by the beneficial effects on comorbidities and mortality. When surgery either fails to completely
remove the pituitary adenoma or is not an option, medical therapy is required for long-term hormone control.
However, control is achieved in only half of patients by the existing therapies. There is a clear unmet medical
need for a therapy that achieves long-term hormone control consistently across the acromegaly patient
population. Elixera’s goal is to develop a novel therapeutic as a first-in-class treatment of acromegaly that fulfills
this unmet medical need. In Phase 1 of this grant, we identified a novel antibody therapeutic that was highly
potent in blocking growth hormone activity. The aim of the Phase 2 grant is to prepare the therapeutic candidate
for manufacture and preclinical toxicology studies and begin clinical trial testing in acromegaly patients.

Public health relevance
Project Narrative: Acromegaly is a rare but potentially lethal disorder of the endocrine system caused by a benign tumor in the pituitary gland that produces excess growth hormone. There is an unmet medical need for drug treatment that can control the growth hormone to within normal levels consistently across the patient population. Elixera has discovered and developed a novel antibody therapeutic for treatment of acromegaly that will be validated in preclinical models before beginning clinical testing.